ILT3 (LILRB4) in anti-tumor immunity and immunotherapy

ABSTRACT
Tumor associated macrophages (TAMs) are key components of the tumor microenvironment and are
associated with immunosuppression, poor prognosis and an inadequate response to immune checkpoint
therapy (ICT) in different types of tumors. Reprogramming of TAMs towards a more phagocytic and “type 1”
pro-inflammatory phenotype can improve tumor control. Thus, several molecules associated with the
immunosuppressive phenotype in TAMs have been targeted in both tumor models and patients, alone or in
combination with ICT. Recently, we showed that the human inhibitory receptor ILT3, also known as LILRB4,
is an attractive target for TAM reprogramming in tumor therapy. We found that ILT3 is highly expressed in
TAMs in various types of cancer. Moreover, we discovered that ILT3 recognizes fibronectin (Fn), which is
ubiquitously expressed in the extracellular matrix and enriched in various primary tumors and metastatic
sites. ILT3-Fn interaction polarizes macrophages and other myeloid cells, such as dendritic cells and
monocytes, towards an immunosuppressive state, which debilitates their capacity to stimulate and activate
T cells. Thus, the ILT3-Fn axis is a mechanism underlying stromal-driven inhibition of anti-tumor activity that
represents a promising target to promote reprogramming of TAMs and myeloid cells in general in cancer. In
this grant application we propose to determine the impact of ILT3 blockade on the control of primary and
metastatic tumor models in vivo with a specific monoclonal antibody, mAb1, that blocks ILT3Fn interaction.
Since ILT3 is a human receptor with a distantly related mouse paralogue, studying its function in vivo has
been difficult. To date, the evidence of ILT3 immunosuppressive activity is based on expression data in
human samples and in vitro assays, while the in vivo impact of ILT3 on myeloid cell functions and anti-tumor
activity remains to be elucidated. To overcome this issue, we generated a transgenic mouse that carries a
bacterial artificial chromosome encompassing a portion of human chromosome 19 that contains the ILT3
gene, together with its putative regulatory regions. Analysis of ILT3 expression in this mouse demonstrated
a pattern consistent with that in humans among different tissues. In specific aim 1, we will test the impact of
ILT3 blockade on tumor growth and anti-tumor immune responses in two models of sarcoma and colorectal
carcinoma in vivo. We will further test the ability of ILT3 blockade to restore an effective response to ICT in
a model of ICT resistance. In specific aim 2, we will test the impact of ILT3 blockade on the composition of
pre-metastatic and metastatic niches in two models of lung metastases and, ultimately, on the formation of
metastatic lesions. This proposal will advance our knowledge of the mechanisms regulating the immune
landscape in primary and metastatic tumors and validate the anti-human ILT3 mAb as a therapeutic agent
that can be brought to the clinic, either alone or in association with ICT.

Public health relevance
PROJECT NARRATIVE Although cancer immunotherapy has drastically changed the course of the disease and favored a durable remission in many patients, some tumors remain resistant to immunotherapy. We propose to study a novel target for cancer immunotherapy called ILT3 (LILRB4) that is highly enriched in macrophages that infiltrate the tumor. Since ILT3 inhibits macrophages, we have developed a blocking antibody that will release macrophages from inhibition, promoting their response and tumor regression.